Robust high-throughput superresolution imaging with speckle illumination

ABSTRACT
Superresolution (SR) fluorescence microscopy has significantly advanced biological imaging but
faces challenges such as the need for specialized molecules, expensive hardware, and long
acquisition times. Structured illumination microscopy (SIM) has been successful due to its
compatibility with standard fluorescent molecules but requires precise control of fringe patterns.
Variations of SIM based on random speckle illumination offer better robustness and easier
implementation but suffer from noise and long averaging times.
This proposal aims to improve speckle-based SIM by developing new algorithms, engineering
speckle illumination, and integrating these into microscopes offering high speed, multicolor and
volumetric (multiplane) imaging. Our overall goal is to develop speckle-based SR platforms that
provide higher throughput than currently available SR technologies, while being able to image
conventional fluorescent molecules with standard labeling protocols. To demonstrate the
benefits of speckle-based SR, we will focus on the application of spatial transcriptomics in
mouse brain tissue, with the aim of achieving higher resolution and faster overall processing
times. Our proposal involves a collaboration between optics and neurobiology labs to establish
the technology of speckle-based SR for practical use.

Public health relevance
Superresolution imaging has been hampered by long acquisition times and requirements of non- standard fluorescent molecules. We propose to develop a superresolution method based on random speckle illumination that can outperform current techniques while remaining simple and robust. We will apply this to high-throughput spatial transcriptomics for genetic profiling of mouse brain tissue.